Rapid Response to Incident HIV Infection through Social Network Strategies and Molecular Epidemiology to Inform Partner Services

PROJECT SUMMARY
The objective of the proposed research is to improve the response to incident HIV infection by engaging the
networks of Black men who have sex with men (BMSM) and transgender women (TGW) through a
combination of Partner Services, social network recruitment, and HIV genetic cluster detection. Despite
marked advances in HIV treatment and prevention, HIV incidence has not substantially declined among
BMSM/TGW in the Southern United States (US), highlighting the need for innovative methods to detect and
respond to ongoing HIV transmission. While Partner Services can be highly effective, case finding remains
limited even for persons diagnosed soon after HIV acquisition (acute or recent infections). Partner Services
can also be limited in investigations across jurisdictional boundaries and in rural areas. We hypothesize that
leveraging the social networks (social contacts rather than only drug sharing or sexual partners) of networks
with recent HIV transmission will lead to improved engagement in HIV services (prevention or care). However,
such strategies must be responsive to the barriers and facilitators to engagement in these services including a
better understanding of social support networks. This project involves a multidisciplinary team including robust
public health partnerships and active community engagement to address HIV prevention needs and build on
existing resources. We will develop and implement an enhanced social network strategy (eSNS) for networks
of BMSM/TGW with new HIV diagnoses, including acute incident infection, in the high-burden Charlotte region
(Mecklenburg County, North Carolina), situated on the border of South Carolina. Both areas are priority regions
in the Ending the Epidemic (EHE) initiative. In the eSNS intervention, new diagnoses will receive rapid
response Partner Services for elicitation of social and sexual contacts; selected contacts will be recruited and
coached to recruit their peers to engage in HIV services. Aim 1 will employ regional genetic and contact
network analysis of incident and prevalent HIV in North and South Carolina, to evaluate important connections
(bridging) between states and between urban and rural areas. This granular data (contact, spatial, genetic) will
expand epidemiological understanding of the epidemic to inform development of the eSNS and enhance local
EHE strategies. To further inform eSNS development, Aim 2 will use a mixed methods approach to examine
the barriers and facilitators of engaging BMSM/TGW members of networks with recent HIV transmission. Aim
3 will then evaluate the eSNS with effectiveness and implementation outcomes. Effectiveness outcomes
(increase in testing, pre-exposure prophylaxis referral, and HIV care engagement) will be evaluated with
regression point displacement design comparing outcomes pre/post intervention in Charlotte and in
comparison, with the Raleigh region receiving standard of care partner services. Overall, the results of this
project will lead to critical information to guide new strategies in Partner Services and in EHE responses to
increase HIV care and prevention engagement among BMSM/TGW in the Southern US.

Public health relevance
PROJECT NARRATIVE Innovative implementation strategies for HIV prevention are needed in the Southern US to decrease HIV transmission. Engaging high risk contacts of sexual and gender minority people with newly acquired HIV through social network methods may have higher yield in reaching those who would benefit from immediate linkage to HIV treatment or prevention services than standard partner services. The proposed research aims to evaluate HIV transmission networks in North and South Carolina, and to develop and implement a partner services intervention to use social network strategy to increase testing and linkage to HIV care or prevention.